Comorbidity: Substance Use Disorders and Other Psychiatric Conditions

Abstract
Introduction: This is a renewal application for T32 institutional training grant application – Comorbidity:
Substance Use Disorders and Other Psychiatric Conditions (NIDA DA037183) -- following the completion of its
first five-year funding cycle. Among the current portfolio of NIDA funded training grants, only one program
other than ours (Dartmouth) has comorbidity as a primary focus. This is striking given co-occurrence
prevalence of Substance Use Disorders (SUD) with other psychiatric conditions and health conditions (e.g.
diabetes), and the extent to which either SUD or the comorbid disorder can go under- or untreated in
conventional treatment settings. The goals, elements and resources of the renewal program retains critical and
effective elements of the initial funding period while incorporating important lessons learned. Long term goals:
The proposed program will develop a cadre of scientists with research expertise in comorbidity mechanisms,
antecedents and correlates, diagnostics, and psychosocial and pharmacological interventions. Component
objectives are to provide each trainee with a working knowledge of comorbidity research including: (a)
translational science from Early Phase Clinical Trials to Community Based Participatory Research
perspectives; (b) effective research strategies for comorbid conditions across populations and ethnic and
cultural groups (e.g. American Indian, Hmong, Somali). Accomplishing programmatic features will capitalize on
(a) the spectrum of faculty expertise providing mentoring across multiple areas, and (b) integration across
training programs and departments. Key Elements: (1) Involvement of scientists and clinicians with diverse
expertise and a core internal advisory group. Primary sites (4 postdoctoral trainees, 2 yrs each) are the
Departments of Psychiatry and Psychology (UMN Twin Cities) and Family Medicine and Biobehavioral Health
(UMN Duluth); (2) Recruitment, including under represented group outreach, of rigorously screened PhD and
MD candidates with SUD and comorbidity as primary career focus; (3) Training with an interdisciplinary
mentoring team (primary & 2 secondary mentors) with complementary expertise; (4) Formal training plans with
clear milestones including trainee development of an NIH application initiated in Year 1; (5) Active research,
seminars, didactic course work, workshops, and development of management, ethics, and regulatory
expertise; (6) Dynamic program administration entailing monitoring with enhancements and problem resolution
along with continued contact with trainees after completion and; (7) Annually convened external advisory
group. Resources: Mentor funding sources include NIH Institutes, NSF, Minnesota Medical Foundation, and
pharmaceutical industry. Key Personnel and Primary Mentors are directors of clinics, centers, or departments
with significant resources.

Public health relevance
Project Narrative Substance use disorders (e.g. alcohol, opioids, cocaine, nicotine) associated with other psychiatric conditions (e.g. depression, anxiety schizophrenia) is the rule rather than the exception. The disorder combinations are not well understood, are often under-treated or untreated, and may relate directly to the causes of addiction and relapse; problems may be exacerbated, or treatment efficacy attenuated, by individual, ethnic and cultural factors. There is a need to train researchers expert in examining biological, psychological and cultural determinants of substance use disorders in combination with psychiatric disorders as a means of providing more effective prevention and treatment strategies for these conditions; this is the focus of the post-doctoral training program.